Exploring post-transcriptional regulators in Acinetobacter baumannii

PROJECT SUMMARY
Bacterial gene expression can be regulated at nearly every conceivable point across the central dogma
of molecular biology where DNA is transcribed into RNA, which is in turn translated into proteins.
Following transcription, mRNA transcripts are subject to regulation by so-called post-transcriptional
regulators, which includes both RNA-binding proteins (RBPs) as well as short (50-500 nt), non-coding
RNA transcripts, referred to as small RNAs, or sRNAs. The post-transcriptional regulation networks
comprised by the sRNAs and associated RBPs are thought to allow bacteria to rapidly respond to
changing environmental conditions by enhancing plasticity within gene expression networks.
Research in my lab combines large-scale, genome-wide analyses facilitated by next generation
sequencing approaches with classic bacterial genetics techniques. We utilize these approaches in a
complimentary fashion; we leverage the sequencing results to inform the genetics experiments, and vice
versa. Ultimately, we use the data to generate and test hypotheses about novel regulatory networks and
regulatory mechanisms, with a particular focus on the RNA binding proteins, sRNAs and post-
transcriptional regulatory networks in the gram-negative bacterium, Acinetobacter baumannii, a notorious
opportunistic human pathogen. A. baumannii is a frequent cause of ventilator associated pneumonia,
skin and soft tissue infections, and other hospital acquired infections. These organisms are amongst the
most problematic species in the context of antibiotic resistance, where extensively drug resistant isolates
present an urgent crisis to our healthcare system, especially considering that contemporary isolates also
demonstrate increased virulence properties relative to ancestral strains.
In this proposal, I present two major research projects in my laboratory, which address key concerns for
understanding bacterial pathogens through the lens of understanding post-transcriptional regulation.
Post-transcriptional regulatory networks remain largely unstudied in A. baumannii. We previously
performed experiments to identify and characterize key RNA-RNA interactions and identified hundreds
of RNA-RNA interactions, suggesting the existence of a robust post-transcriptional regulatory network in
A. baumannii. In this proposal, we propose to systematically dissect relevant RNA-RNA interactions that
are mediated by a key RNA binding protein, called Hfq, and further characterize how this essential protein
integrates RNA-mediated regulation with cellular RNA processing enzymes. Collectively, the results of
these studies will provide a comprehensive picture of the sRNA regulatory landscape in a significant
bacterial pathogen and will enhance our understanding about the post-transcriptional regulatory network
coordinates gene expression in the context of human disease.

Public health relevance
NARRATIVE Despite the first discovery of small, non-coding regulatory RNA molecules (sRNAs) in bacteria nearly 50 years ago, a key challenge to understanding the intricacies of post-transcriptional regulation is that we have, until recently, lacked experimental tools to readily identify the RNA targets of bacterial sRNAs. A further limitation is that much of our knowledge about bacterial sRNAs, post-transcriptional regulation, and RNA processing is based on studies performed in non-pathogenic, laboratory adapted strains of E. coli. This proposal seeks to address these shortcomings by coupling state-of-the-art next-generation sequencing technologies with classical bacterial genetics approaches to uncover novel aspects of post- transcriptional regulatory networks in an emerging bacterial pathogen.